EFFECT OF FASTING ON UDP-GLUCOSE FLUX IN HUMANS

The purpose of this study is to determine how fasting affects how the body stores sugar within the liver in normal subjects. The results in dog studies showed a nearly two-fold increase in UDP-glucose turnover, as well as a nearly three-fold increase in the amount of UDP-glucose coming through the indirect pathway with two additional days of fasting. The hypothesis to be tested is that in normal volunteers, increased fasting will increase UDP-glucose turnover and the percentage of UDP- glucose turnover coming through the indirect pathway. This study is one in a series of studies that seeks to further our understanding of one aspect of glucose homeostasis, specifically the substrate and hormonal factors which affect the rate of glycogen synthesis in vivo.